CORE--IMAGING

The imaging core facility is located on the sixth floor of the Medical Science Building (MS620) and encompasses 250 square feet of space. The imaging core houses three epifluorescence microscopes (Nikon Eclipse 600, Zeiss Axiovert 100 and 200M) with digital image capture capability (Spot CE and Orca ER digital cameras with Metaview and Open Lab software). The Eclipse 600 will allow the high resolution imaging of cells and sub-cellular compartments. This instrument can be used for detailed analysis of various cellular structures. The core also contains two inverted epifluorescence microscopes. The Axiovert 200M is equipped with stage controllers to allow long term analysis of live cells. The Axiovert 100 can be used for analysis of cells in tissue culture dishes or fixed samples on slides. The flexibility of the instruments in the facility will enable the core users a wide range of analytical techniques with which to pursue their individual projects. The facility contains two computers for image processing. The computers have complete Internet access and network access to color printers and to data storage. Dr, Whiteheart will be available to offer advice on sample preparation, on data analysis, and on imaging procedures. In addition, Dr. Whiteheart will also advise in the preparation of figures and selection of images for publication.